JHU Admin Core

Modified Project Summary/Abstract Section

ADMINISTRATIVE CORE
ABSTRACT
The Administrative Core of the Johns Hopkins O’Brien Center to Advance Kidney Health (JHOC) will provide the overall administration of the Center, leading, managing, and harmonizing all aspects of the Center and ensuring that Center resources are shared nationally. The Administrative Core will be led by Dr. Deidra Crews and Dr. Chirag Parikh (as Co-Directors). Their complementary research approaches underscore the Center’s ability to enable research along the entire research continuum from bench to community. The Specific Aims of the Administrative Core are to: 1) provide administrative support to JHOC Cores and coordinate the Center activities to maximize resource development and dissemination; 2) collaborate with the National Coordinating Center to prioritize external requests for resources and enhance national outreach; 3) plan and execute an annual Summer Student Enrichment Program which leverages a long-standing partnership with a Johns Hopkins program; 4) foster the careers of early-stage investigators by promoting trans-disciplinary and cross-sector collaboration, including with an established Community Advisory Board; 5) create and maintain an updated website to communicate about center resources; and 6) engage an Internal Advisory Committee to evaluate effectiveness and outcomes for the Center. Each of these components will work together through the Administrative Core to enable research in kidney health to thrive and expand